Terahertz time-domain spectroscopic imaging of cornea for three dimensional mapping of hydration gradients

Project Summary
There are several ophthalmological diseases and ailments that perturb the normal water content or hydration
levels of the corneal layer. Among these, Fuchs’ dystrophy, keratoconus, and elevated intraocular pressure (IOP)
- a common cause of glaucoma, to name a few examples, can have a drastic impact on the patients’ vision. The
work outlined in this proposal will develop terahertz spectroscopy instruments that enable spatially and spectrally
resolved measurements across the entire corneal surface to map hydration gradients of the tissue in various
disease models. Specifically, our hypothesis is that terahertz time-domain spectroscopy (Thz-TDS) can
simultaneously measure axially and spatially varying hydration gradients due to elevated IOP or surgical
disruption of the endothelial layer of the cornea using spectral multi-layer reflections from various corneal layers.
We will test this hypothesis through the following specific aims:
(1) We will determine the accuracy of a THz-TDS corneal scanner in hydration measurement of corneal
phantoms and ex vivo models.
(2) We will determine the sensitivity and specificity of THz-TDS imaging in mapping corneal hydration
gradients using two in vivo experimental models.
Results from these studies will determine the potential of THz-TDS technique as a new non-contact corneal
imaging modality to accurately measure and map corneal hydration gradients. Moreover, the developed in vivo
scanning instrument, and the methodology potentially can be used for diagnosis or as a research tool in studying
disease that perturb corneal hydration such as Fuchs’ dystrophy or in evaluation of viability of corneal transplant
surgeries.

Public health relevance
Project Narrative Public Health Relevance: The proposed research project will explore the utility of terahertz time-domain spectroscopic imaging to measure and map corneal hydration gradients. Patients afflicted with several corneal diseases experience perturbation to corneal hydration levels and its opacity, which in turn can impact vision acuity. Early detection and monitoring of such diseases is key to successful treatment, yet the sensitivity and specificity of clinical techniques are insufficient to provide diagnosis at the early stages.